The Development of Youth Resilience to Neighborhood Disadvantage

Project Summary/Abstract
Much of the youth resilience literature to date has focused on resilience to family adversity, with far less
examining resilience to neighborhood adversity. This is a key gap in the literature because neighborhood
disadvantage is a robust indicator of poor outcomes throughout the lifespan. The focus on only one type of
resilience (psychiatric) to the exclusion of others (social, emotional, and academic) and the inconsistent
evidence of stability in resilience across development further exacerbate this gap. The transitions from middle
childhood to adolescence and adolescence to emerging adulthood are important developmental periods
marked by agency, cognitive, and self-regulation gains. The proposed research aims to examine not only how
resilience can change from middle childhood to adolescence and to later emerging adulthood, but whether
these developmental changes vary by type of resilience (psychiatric, social, emotional, academic), and finally,
how those changes might differ with protective factors (i.e., warm and involved parenting, structural
neighborhood protective features). During the K99 phase, Specific Aim 1 will investigate trajectories of the
multifaceted conceptualization of resilience from middle childhood to adolescence and Specific Aim 2 will
examine how these resilience trajectories may change when considering the protective factor of warm and
involved parenting. During the R00 phase, Specific Aim 3 will investigate how a comprehensive set of positive
structural neighborhood features (previously linked to resident well-being) promote youth resilience during the
critical transitions between middle childhood and emerging adulthood. Dr. Elizabeth Shewark’s background in
developmental psychology, family systems, advanced methods, and neighborhood effects uniquely positions
her to carry out this line of research. Dr. Shewark’s long-term career goal is to lead an interdisciplinary
research team that investigates how and by what mechanism(s) the contexts in which youth are developing
impact their resilience. To independently lead this future research team, the goal of this Pathway to
Independence Award is to build expertise in youth resilience to neighborhood adversity, and gain further
training in cutting edge longitudinal analytic techniques, the assessment of positive structural neighborhood
features, and conducting research in vulnerable at-risk populations. The proposal includes a highly established
group of researchers who will strengthen the interdisciplinary impact of Dr. Shewark’s work and her
development into an independent researcher. The theoretical knowledge and methodological skills gained
during this project will allow Dr. Shewark to produce a rich body of research on how warm and involved
parenting and structural neighborhood protective factors shape the development of youth resilience, facilitating
the identification of modifiable targets for intervention programs to promote healthy youth development.

Public health relevance
Project Narrative Neighborhood disadvantage (e.g., poverty and exposure to violence) is a robust indicator of youth adjustment difficulties across most domains of development, yet there are youth who thrive despite significant neighborhood adversity. This project investigates: (1) how resilience changes as youth reach important developmental milestones and freely explore their environments, (2) whether these developmental changes differ by resilience domain (psychiatric, social, emotional, academic), and (3) how warm and involved parenting as well as neighborhood protective factors might shape their development. In doing so, the proposed project can identify specific and modifiable protective factors that promote resilience to chronic neighborhood risk.